Core B - Tissue Procurement, Pathology, and Genomics

CORE B: ABSTRACT
Core B, Tissue Procurement, Pathology, and Genomics will be led by Drs. Alina Iuga, MD, and Katherine A.
Hoadley, PhD. This core will support the SPORE projects through sample collection, tracking, translational
pathology, genomics, and data analysis. The core takes advantage of existing infrastructure supported by the
Lineberger Comprehensive Cancer Center to provide SPORE investigators with access to quality samples and
data. The development of an integrated laboratory information system and database tracking and management
system will allow for easy tracking and transition of data and information from the hospital to tissue banking to
pathology and genomic services. The PIs of the core bring expertise in pancreatic cancer, pathology and
genomics and will provide guidance and data analysis for the projects.

Public health relevance
CORE B: PROJECT NARRATIVE The Tissue Procurement, Pathology, and Genomics (TPPG) Core will assist SPORE projects with expertise and guidance in pathology, genomics, and data analysis and will provide investigators with research specimens and clinical data. TPPG will provide database support for collecting, tracking, and distributing data and will ensure rigor, reproducibility, and transparency within all SPORE projects.